Influenza and Other Emerging Infectious Diseases in Vietnam (U01)

DESCRIPTION (provided by applicant): Research on human and animal influenza in Vietnam will provide new information important in the design and implementation of prevention, control, and treatment strategies and policies required to reduce infection, illness and death from influenza in Vietnam and neighboring countries and will assist in the early detection, treatment, control, and containment of influenza viruses having potential for global spread. The proposal comprises 5 subproject studies that address specific announcement aims and objectives: 1) Co-evolution of human and animal Influenza A viruses, Vietnam, including circulating human seasonal strains as well as highly pathogenic animal strains, including avian influenza A/H5N1 viruses, using genomic sequencing, bioinformatics methods on virus isolates from humans and animals throughout Vietnam; 2) Epidemiology of Influenza A/H5N1 in humans, Vietnam: retrospective summary statistical review and univariate analyses of 108 confirmed cases, 2003-2008; 3) Epidemiology of Influenza A/H5N1 in humans, Vietnam: case-control study of risk factors for infection and disease; 4) Burden of influenza-related acute lower respiratory tract infection (ALRTI) in 3 selected district hospitals, Vietnam; 5) Development of improved methods for the diagnosis of influenza in humans in Vietnam, especially the pilot evaluation of a new and improved method for rapid antigenic identification of A/H3,H1,H5 virus subtypes at point-of-care. PUBLIC HEALTH RELEVANCE: Seasonally circulating human influenza strains are a major cause of illness in Vietnam, and are also an important cause of excess deaths based on knowledge from countries where the disease has been more thoroughly studied. Infection of humans and animals with the highly pathogenic avian influenza virus (A/H5N1) has since 2003 caused a huge public health and economic burden on Vietnam, resulting in the loss of over 50 million poultry and 108 human cases and 52 case deaths. There is a high global concern that viruses circulating in Vietnam could through genetic mutation or re-assortment result in rapid global spread of a new and highly pathogenic strain of virus potentially causing a global emergency with 50 million or more deaths and severe socioeconomic disruptions. A better understanding of the virus evolution, risk factors for infection, the epidemiologic characteristics of influenza illness in communities and its burden, and the development and evaluation of new and improved diagnostic test methods can lead to improved influenza treatment, prevention, control and containment, including for avian and pandemic influenza.

Public health relevance
Project Narrative: Seasonally circulating human influenza strains are a major cause of illness in Vietnam, and are also an important cause of excess deaths based on knowledge from countries where the disease has been more thoroughly studied. Infection of humans and animals with the highly pathogenic avian influenza virus (A/H5N1) has since 2003 caused a huge public health and economic burden on Vietnam, resulting in the loss of over 50 million poultry and 108 human cases and 52 case deaths. There is a high global concern that viruses circulating in Vietnam could through genetic mutation or re-assortment result in rapid global spread of a new and highly pathogenic strain of virus potentially causing a global emergency with 50 million or more deaths and severe socioeconomic disruptions. A better understanding of the virus evolution, risk factors for infection, the epidemiologic characteristics of influenza illness in communities and its burden, and the development and evaluation of new and improved diagnostic test methods can lead to improved influenza treatment, prevention, control and containment, including for avian and pandemic influenza.